RFA-IP-22-004, Platform to Assess Influenza and COVID-19 Vaccine Effectiveness in Underserved Arizona Populations

Component A – Abstract:
Annual influenza vaccination is the primary prevention strategy for infection and severe disease. A constantly
evolving influenza virus through antigenic drift dictates that vaccines are re-evaluated every year. COVID-19
has overlapping symptoms with influenza and has significantly complicated the healthcare burden associated
with viral infections, morbidity, and mortality. While COVID-19 vaccines received Emergency Use Authorization
(EUA) from the Food and Drug Administration (FDA), additional COVID-19 vaccines are under development
due to emerging variants, some of which are known to evade currently authorized vaccines. As such, boosters
are recommended to thwart spikes and new waves of variant infections which complicates assessment of the
effectiveness of both COVID-19 and seasonal influenza vaccines simultaneously. Phoenix, Arizona is the fifth
largest and fastest growing city in the nation, and, importantly, is home to an ethnically and socioeconomically
diverse population. Twice during the COVID-19 pandemic, Arizona was #1 worldwide in per capita COVID-19
cases. Arizona has seen a mixed adoption of vaccine use for both COVID-19 and influenza, allowing for
excellent local comparisons. In this project, leveraging Arizona State University’s (ASU) core capabilities, we
propose to study vaccine effectiveness (VE) in a diverse demographic and clinical population (including
immunocompromised HIV patients) seen at outpatient clinics managed by ValleyWise Community Hospital,
Phoenix Children’s Hospital and ASU Student Health Services. Given identified health disparities in infection
and vaccination, we propose to examine social determinants of health to identify the most vulnerable groups.
We will collect specimens (nasopharyngeal and/or anterior nasal swabs) and relevant demographic and clinical
data from laboratory-confirmed cases of influenza and COVID-19 in children and adults with acute respiratory
infection, seeking care in ambulatory clinics, to calculate vaccine effectiveness for both influenza and COVID-
19 vaccines. We will also sequence viral genomes to identify subtype/variants using our deep expertise and
incomparable resources in next-generation sequencing and viral genomic bioinformatics. We will use this
genomic sequencing data to further investigate VE analyses and understand virus evolution. Importantly, to
examine health disparities in vaccination and vaccine effectiveness, we will implement longitudinal surveys and
geographical information systems mapping to measure and model social determinants of health. Overall, our
multidisciplinary program provides a comprehensive approach to study VE and to understand social
determinates that drives health disparities. We believe the findings will have important, long lasting policy
implications towards vaccination and examination of VE.

Public health relevance
Component A – Project Narrative: Vaccine effectiveness is a measure of how well a particular vaccine protects people against infection, symptomatic illness, hospitalization, and death in a real-world condition. This research aims to provide accurate estimates of the effectiveness of influenza and COVID-19 vaccines against respiratory virus- associated illness in that population, in the context of varying social determinants of health disparities.